Sex Differences in Cardiometabolic Health and Disease

Overall
SUMMARY
The objective of our SCORE on “Sex Differences in Cardiometabolic Health and Disease” is to identify
factors that determine sex-specific cardiometabolic disease risk, which may lead to better diagnosis and
treatment for both sexes. A unique feature of our program is the investigation of sex differences from multiple
perspectives, including effects of estrogen, of XX vs. XY sex chromosome genes, and of genetic variation
among individuals. Our program consists of three research projects and three cores, and will use preclinical
mouse models, human induced pluripotent stem cell lines (iPSCs), and existing human population datasets
(genomic, transcriptomic, proteomic, and metabolomic) to translate findings from our model systems to
humans. Project 1, “Epigenetic sex determinants of cardiometabolic disease and prevention,” will build on our
identification of X and Y chromosome genes that influence sex differences in both the development of diet-
induced obesity and susceptibility to adverse effects of statin drugs. We will elucidate the role of three X-Y
histone demethylase genes in epigenetic sex differences in mouse adiposity and human adipocyte
differentiation. We will also identify the epigenetic determinants of sex-biased statin adverse effects on
mitochondrial function. Project 2, “Gene-by-sex interactions in heart failure with preserved ejection fraction
(HFpEF),” seeks to understand the mechanisms underlying increased prevalence of HFpEF in women
compared to men. Using a “systems genetics” approach and a panel of genetically distinct mouse strains, the
goals are to understand sex differences in HFpEF traits at the molecular level, including the role of gonadal
hormones and sex chromosomes, and to create sex-specific biologic networks that can be generalized to
humans. Recent findings implicate sex differences in the mitochondrial enzyme, ACSL6, as causal for HFpEF,
and further studies will characterize the role of mitochondrial dysfunction in HFpEF. Project 3, “The impact of
estrogen receptor alpha on cardiomyocellular metabolism and health,” will test the hypothesis that estrogen
receptor alpha action in cardiomyocytes impacts mitochondrial metabolism, cardiac tissue integrity and heart
function. Findings with unique cardiomyocyte estrogen receptor alpha knockout or overexpression mouse
models will then be integrated with human data in collaboration with our Human Translational Bioinformatics
Core. The Human Translational Bioinformatics Core will serve as hub for computational analyses to
translate findings from the three Projects for association and relevant to cardiometabolic traits in humans using
existing large human genetic and –omics datasets. The Career Enhancement Core will foster research in sex
differences in metabolism by administering a Pilot & Feasibility grant program, and will educate researchers
and students about SABV through courses, hands-on laboratory ‘bootcamp,’ and a library of SABV videos. The
Administrative Core will ensure effective leadership and management of this SCORE.

Public health relevance
OVERALL: Sex Differences in the Cardiometabolic Health and Disease NARRATIVE Men and women differ in their risk for the development of cardiometabolic diseases, and in their response to widely used preventive drugs. We are dedicated to understanding the reasons for these sex differences, and will study the effects of hormones and genetic factors. Our studies will allow the development of therapies that will optimally benefit both women and men.